Understanding the mechanisms of iron addiction in colon cancer

ABSTRACT
Colorectal cancer (CRC) can be effectively treated if detected early. However, most tumors are detected at
an advanced stage when treatment options are limited. There has been a resurgence in assessing altered
cell metabolism in cancer growth. Unlike normal cells, cancer cells rely mainly on aerobic glycolysis for ATP
production. Aerobic glycolysis is inefficient in ATP generation, but the glycolytic and TCA cycle
intermediates are rerouted for the production of biomass. These studies have led to identification of several
critical pathways that have the potential to be therapeutic targets. Currently, much less is known about the
contribution of micronutrient metabolism in cancer. Our recent work has established that iron accumulation
is critical step in the growth and progression of colon cancer. Colon cancer cells are addicted to high iron
levels for cell proliferation. We have clearly shown that there is an accumulation of intra-tumoral iron
compared to adjacent normal mucosa. Genetic or dietary restriction of iron leads to a robust decrease in
tumor proliferation and progression. However, it is unclear how cancer cells maintain high iron levels,
resistant to iron-mediated oxidative toxicity and utilize iron for signaling, survival, and growth. Our goals are
to identify mechanism underlying these major gaps to lay the foundation for iron-based therapies in colon
cancer. We hypothesize that CRCs bypass the toxicities of high iron accumulation to fuel oncogenic
signaling. Cellular iron levels are regulated via a hepatic hormone hepcidin. Hepcidin binds to an iron
exporter ferroportin leading to degradation and inhibition of iron export. We show that colon tumor
epithelium express high levels of hepcidin and low ferroportin. Aim 1 will delineate if hepcidin/ferroportin
axis is the major mechanism leading to iron accumulation and if it can be targeted for therapy. Iron is
essential for growth but can be highly toxic to a cell. Iron levels need to be tightly controlled. Iron via the
Fenton reaction leads to high superoxide formation and initiates a form of non-apoptotic cell death called
ferroptosis. Our recent data suggest that CRCs actively suppress ferroptosis. Aim 2 will understand
mechanisms leading to resistance of iron induced damage. In Aim 3 we will address why CRCs need high
levels of iron to maintain growth. Our previous work showed that iron can directly activate oncogenic
kinases through a putative posttranslational modification we termed ferritinylation. In this Aim we plan to
explore the importance of ferritinylation using cell models and patient-derived organoid models.
Accomplishing these Aims will (i) uncover mechanisms of iron accumulation (ii) define novel iron
related vulnerabilities, and (iii) characterize how iron drives oncogenic signaling in CRC. These studies
will also highlight new pathways, genetic vulnerabilities and drug targets for CRC.

Public health relevance
PUBLIC HEALTH RELEVANCE Colon cancer is a deadly cancer and new treatments are needed. Iron accumulation is an essential mechanism, which drives colon cancer progression. This grant will characterize mechanisms critical for iron- mediated growth, and identify new targets for the prevention and treatment of colon cancer.